Administration Core

The Administrative Core manages, coordinates and facilitates NEIDL operations including facilities maintenance, public safety, environmental health and safety, and all integrated research support services to provide research resources and infrastructure to enable the development of next generation therapeutics, diagnostics and vaccines for emerging and re-emerging infectious diseases. The Administrative Core provides resources and strategic direction to the Community Relations core via direct participation in community relations activities. The Core also leads and facilitates the implementation of regulatory requirements and best practices related to biosafety and biosecurity and interacts with NIAID staff, the Regional Centers of Excellence (RCE’s), and other members of the NBL/RBL network in support of the national biodefense research agenda. The Administrative Core represents the NEIDL to BU administration through participation in numerous BU committees and meetings with the provost of the medical campus and other senior leaders and manages the coordination and implementation of BU initiatives within the NEIDL including the promotion and maintenance of a culture of safety in all laboratory operations. In addition, the Administrative core manages all NEIDL Institute administrative and scientific support activities including the review process for all scientific projects requesting access to the NEIDL services and facilities. This core manages NEIDL finances including the development of a comprehensive business plan and development and implementation of service center cost recovery procedures for the integrated research support services cores.

Public health relevance
The NEIDL Administrative Core manages research programs and activities of the integrated research support service and operations core facilities which facilitate basic, translational and clinical research and the development of products related to the emerging infectious diseases agenda.